Establishing Mechanisms of Benefit to Reinforce the Alzheimer's Care Experience AD/ADRD Roybal Center: EMBRACE

Program Summary/Abstract-Administrative Core
Robust research infrastructure capable of advancing the science of dementia care interventions in the
home and community is necessary. Such infrastructure should reflect the integration of concentrated and
synergistic areas of scientific expertise encompassing all components of the NIH Stage Model, dementia care
interventions, community engagement, and recruitment and retention. Our proposed AD/ADRD Roybal Center,
Establishing Mechanisms of Benefit to Reinforce the Alzheimer’s Care Experience (EMBRACE), addresses
this need by assembling an interdisciplinary team that synergizes these areas of expertise to establish a strong
research infrastructure to facilitate the science of mechanistically driven dementia care interventions.
The primary objective of the Administrative Core (AC) is to provide governance, oversight, and systematic
coordination of activities of EMBRACE. The AC will provide focused leadership and structure for all EMBRACE
activities including its solicitation, review, awarding, and monitoring of clinical trials; coordination of the External
Advisory Committee (EAC); evaluation of the overall Center and progression of awarded Investigators;
coordination with the Roybal Coordinating Center to advance the overall mission of NIA’s Roybal Program; and
dissemination and network building with other Roybal and NIA-funded Centers. Together, these activities will
cultivate a vibrant community of scientists engaged in testing mechanisms of action in dementia care
interventions as emphasized in RFA-AG-24-007. The Specific Aims of the EMBRACE Administrative Core are
to: 1) Provide governance and administration of EMBRACE; 2) Support the scientific activities and functions of
EMBRACE by coordinating solicitation and review of applications with the Behavioral Intervention
Development Core; and 3) Facilitate the development of research networks and collaborations within and
beyond EMBRACE that advances a mechanistic science of dementia care interventions. In accomplishing
these Aims, EMBRACE will in turn achieve its objective of generating extensive and substantive research
capacity to advance the development and advancement of potent and mechanistically oriented dementia care
interventions in home and community settings across the NIH Stage Model.